Mechanisms underlying TDP-43 dependent structural deficits in ALS muscles

ABSTRACT
Amyotrophic lateral sclerosis (ALS) is fatal neurodegenerative disease that affects 2/100,000 individuals
worldwide. The disease is caused by motor neuron dysfunction and death, which in turn causes paralysis
within 2-5 years of diagnosis. A pathological hallmark of ALS is the presence of cytoplasmic aggregates
containing the DNA/RNA binding protein TDP-43 in 97% of ALS cases. Furthermore, TDP-43 is associated
with cytoplasmic aggregates across a broad range of neuromuscular and neurodegenerative disorders
including ALS, inclusion body myositis (IBM) and fronto-temporal dementia (FTD). While a plethora of studies
have focused on TDP-43 pathophysiology in neurons and glia, much remains unknown about TDP-43
proteinopathy in muscle, the cell type most visibly affected by ALS as it undergoes rapid atrophy. TDP-43 loss
of function has been shown to cause muscle weakness and degeneration in mice, zebrafish and flies. Recent
studies have shown that TDP-43 associates with myogranules and plays a role in muscle formation, likely by
regulating cytoplasmic mRNAs, including several that encode sarcomeric proteins such as titin and myosin
heavy chain. In addition to their physiological role in muscle differentiation and regeneration, TDP-43
containing myogranules are also present in mouse models of IBM, consistent with also having a role in disease
pathomechanisms. Furthermore, these findings suggest that TDP-43 containing myogranules provide an
opportunity to uncover differences between protective and toxic aggregates.To address the gap in knowledge
regarding TDP-43 pathophysiology in muscles, we set out to study TDP-43 dependent, muscle specific
alteration in newly synthesized proteins. Preliminary results using Non-Canonical Aminoacid Tagging (NCAT)
in vivo, in the context of Drosophila models of TDP-43 proteinopathy show that TDP-43 overexpression in
muscles causes a marked reduction in newly synthesized proteins involved in translation itself, myofibril
assembly, mitochondria and nuclear pores among others. We hypothesize that similar to its neuronal role,
TDP-43 alters the translation of specific mRNA targets in muscles, and this in turn may impact the
morphology and/or function of muscles, and contribute to the muscle atrophy observed in patients. We
will test this hypothesis by first identifying TDP-43 translation targets in vivo, in Drosophila muscles using both
overexpression and loss of function approaches (Aim 1). Next, we will validate candidate targets in fly muscles
and patient tissues (Aim 2). These studies are poised to identify novel, muscle specific therapeutic targets of
TDP-43 proteinopathies and related neuromuscular disorders.

Public health relevance
PROJECT NARRATIVE Amyotrophic lateral sclerosis (ALS) is fatal neurodegenerative disease characterized by the presence of cytoplasmic aggregates containing TDP-43 in 97% of ALS cases. Here we will investigate the molecular mechanisms underlying TDP-43 proteinopathy in muscle, the cell type most visibly affected by ALS, using a combination of Drosophila models and patient tissues. These studies may uncover novel therapeutic strategies for ALS and related neuromuscular disorders.